West African Emerging Infectious Disease Research Center (WA-EIDRC)

Abstract
Ensuring a world safe from microbial threats is a pressing challenge, as outbreaks exact tolls on human health, disrupt regional security, and have the potential to rapidly escalate into global crises. In recent years, severe outbreaks of Ebola, Lassa, Zika, and other emerging viruses have illustrated how vulnerable the world is to threats from RNA viral pathogens. These public health emergencies have exposed the urgent need for improved infrastructure, scientific knowledge, and diagnostic tools in areas of the world most at risk, and underscore the need for proactive pathogen surveillance, detection, and discovery. West Africa has a disproportionate vulnerability to outbreaks, but we lack awareness of acute threats, their natural history, and effective strategies for prevention. Rooted research between local and global partners, combined with novel assays and strategies for pandemic preparedness is required to answer these questions. We will build the capacity to rapidly respond to future outbreaks by establishing the West African Research Network for Infectious Diseases. This network will expand on years of successful cross-disciplinary research and capacity building, bringing together leading researchers from the United States, Liberia, Nigeria, Senegal, and Sierra Leone. We will: (1) perform comprehensive surveys of acute RNA viral disease and determine critical threats circulating in hosts and reservoirs; (2) identify risk factors of virus transmission and evolution; (3) dissect pathogenesis and natural history of severe RNA viral diseases; and (4) determine diagnostic criteria for infection outcome to guide public health interventions. Our work will significantly expand research capacity in West Africa via technology development of novel solutions for surveillance, diagnostics, and pathogen discovery. By establishing our network with a focus on priority pathogen research, technology transfer, training, and capacity building, we will develop flexible strategies for detecting, mitigating, and preventing the emergence of future infectious disease outbreaks.

Public health relevance
PUBLIC HEALTH RELEVANCE: In recent years, severe outbreaks and epidemics of Ebola, Lassa, and Zika have illustrated how vulnerable the world is to threats from RNA viral pathogens. To counter the dangers posed by these viruses, we must develop flexible and scalable technologies for diagnostics, surveillance, pathogen discovery and transmission, and deploy them in the most outbreak-prone regions of the world. Here, we will establish the West African Research Network for Infectious Diseases with partners in the United States, Senegal, Sierra Leone, Liberia, and Nigeria, to develop effective strategies, and deploy the necessary tools, for detecting, mitigating, and preventing future outbreaks from emerging and re-emerging infectious diseases.